Data Management and Analysis Core

DATA MANAGEMENT AND ANALYSIS CORE: PROJECT SUMMARY
The Data Management and Analysis Core (DMAC) will serve as the centralized hub for the data generated
across all projects from the Southern California Superfund Research and Training Program for PFAS
Assessment, Remediation and Prevention Center (ShARP). This includes: Single cell RNA-transcriptomic
(scRNA-Seq), single-cell (sc)ATAC-seq, proteomics, and metabolomics data that will be generated as part of
Project 1 and used to inform analysis in Project 2 and Project 4; PFAS plasma concentrations, clinical data
including liver fat, questionnaire data including diet and drinking water consumption habits, and residential history
for Project 2 and used to inform analysis in Project 1; Measurements and predictions of targeted and untargeted
PFAS levels in various environmental matrices generated from measurements and prediction models developed
in Project 3 and used to inform analysis in Project 1; and data on estimated PFAS levels following novel PFAS
remediation strategies, including the percent reduction in PFAS levels under different treatment strategies and
data on partially defluorinated chemicals generated in Project 4 and used to inform analysis in Project 1, Project
2, and Project 3. This diverse data requires a comprehensive data solution consisting of a locally stored
database, and a cloud-based data and analysis system that facilitates data integration. The DMAC will support
cores and projects via comprehensive data quality control pipelines, available for utilization by all cores and
projects, and extensive statistical and bioinformatics support and expertise reflected in DMAC personnel. As a
cohesive unit, the DMAC will leverage familiarity with data resources and commonalities of analysis across
projects and cores and will provide additional supplemental support for integrated statistical analysis and cross-
component access of joint results across projects. The core functionalities of the DMAC will enable the
widespread accessibility that is critical to ensuring the success of ShARP.

Public health relevance
DATA MANAGEMENT AND ANALYSIS CORE: PROJECT NARRATIVE The Data Management and Analysis Core (DMAC) within the Southern California Superfund Research and Training Program for PFAS Assessment, Remediation and Prevention Center (ShARP) will provide a local and cloud-based data management system for the entire Program Project that will enable Project-specific analyses, as well as integrated analyses utilizing data spanning the entire Project. The DMAC will serve as the centralized hub for the data generated across all projects from the ShARP Center. The DMAC is essential to the overall success of ShARP, as it serves as an incubator to process and store data, advise and complete Project-specific analyses, and accelerate cross-Project integration and discoveries.